Mechanisms underlying the effects of time-restricted feeding on lipid metabolism

Project Summary
Today, we live in an age of unprecedented access to food. Recent research suggests that many Americans eat
from the time they wake up to the time they go to sleep. Night eating, specifically, is linked to several aging-
related comorbidities, including obesity, cardiovascular disease, and type-2 diabetes. While much ongoing
research investigates the mechanisms by which dietary components affect metabolism, it is less understood how
the timing of feeding affects metabolism. To this end, dietary interventions that alter the timing of feeding have
been shown to protect many aspects of health, even without reducing caloric intake. Time-restricted feeding
(TRF) diets have been shown in mice and humans to reduce oxidative stress and inflammation, decrease insulin
resistance, lower blood sugar. In mice, TRF has been shown to reduce fat levels, protect against a high-fat diet,
and prevent obesity. Using Drosophila melanogaster, the Shirasu-Hiza lab developed a robust TRF diet that
extends lifespan and delays molecular signs of aging, such as protein aggregation, and showed that TRF
enhances circadian gene expression and requires the circadian clock to confer lifespan benefits. In addition, we
found that TRF seems to reprogram lipid metabolism; after TRF treatment, flies responded to fasting by utilizing
lipids much faster than controls, leading to increased rate of triacylglyceride loss and starvation sensitivity. I
found that this TRF-accelerated lipid usage, like TRF-induced lifespan extension, requires circadian components
but, unlike TRF-induced lifespan extension, does not require autophagy components. Because the underlying
mechanisms remain unclear, I propose to identify molecular components that drive the effects of TRF on lipid
metabolism. I will use Drosophila melanogaster, an advantageous model organism for this work because: many
mammalian metabolic pathways are conserved in flies; flies have short generation time (2-3 months); and flies
offer a plethora of powerful genetic tools. Aim 1 will identify specific tissue(s) in which circadian regulators are
required for TRF-accelerated lipid usage. Aim 2 will examine the molecular mechanisms by which TRF changes
lipid metabolism. I will use RNA-sequencing analysis to identify transcriptional differences between TRF-treated
flies and their controls; significantly differentially expressed genes and/or pathways will be assessed for their
functional role in TRF-accelerated lipid usage. Aim 3 will investigate the therapeutic potential of TRF in diet-
induced obesity. Flies fed a high-sugar diet and have hallmarks of obesity will be treated with TRF to test if
obesity-related phenotypes are ameliorated upon TRF treatment; we will test both young and old flies. These
experiments will determine the molecular mechanisms connecting TRF to lipid metabolism and how TRF can be
used to ameliorate obesity- and aging-related pathologies. This will improve our understanding on how TRF can
confer health span benefits while also testing its therapeutic potential in aging-related, diet-induced obesity.

Public health relevance
Project Narrative While night-eating increases the risk of obesity and other aging-related comorbidities, such as type-2 diabetes and cardiovascular disease, time-restricted feeding has been found to ameliorate these effects. This proposed work will investigate how time-restricted feeding accelerates lipid metabolism to confer health span benefits and in the context of diet-induced obesity. This will improve our understanding of the molecular mechanisms underlying the health benefits of time-restricted feeding and the therapeutic potential of time- restricted feeding in diet-induced obesity.